Transcriptomic, physiological, and neurochemical profiling of cortico-limbic projection neurons in monkey anterior cingulate cortex

ABSTRACT
The anterior cingulate cortex (ACC) is heavily interconnected with the lateral prefrontal cortex (LPFC) and limbic
structures such as the amygdala (AMY), forming pathways important for cognitive and affective processing.
Human neuroimaging studies have shown that the ACC exhibits differential control of LPFC and AMY to
modulate distinct limbic and cognitive functional resting state networks with anti-correlated activation patterns.
Ascending brainstem neuromodulatory pathways that control arousal and stress influence the neurochemical
environment and activity in these cortico-limbic networks through modulating intrinsic excitability and synaptic
signaling in specific areas, layers, and cell types. Understanding the as yet unknown cell type-specific molecular
signatures of neuromodulatory signaling pathways -- the receptor expression profiles and downstream gene
network targets– in the primate ACC, a key cortico-limbic hub, will allow us to identify novel biomarkers for
neurochemical imbalance and cellular damage that confer vulnerability to emotional stress. The recent
advancement in single-cell RNA sequencing (scRNAseq) has allowed to uncover molecularly-defined neuronal
subclasses in mouse cortex. However, there is a big knowledge gap in our understanding of how layer-specific
molecular neuronal identity affects electrophysiological properties and the formation of neuronal interconnections
in primates and humans. The overall hypothesis of this proposal is that the lamina-specific ACCAMY and
ACCLPFC projection neurons have distinct molecular signatures that underlie their neuromodulatory signaling
properties and regulation of excitability and synaptic connections. We propose to determine the gene expression
profile of individual lamina-specific ACC cell types and projection neurons, focusing on the differential expression
of receptors and signaling pathways related to arousal and stress. We will combine neural tract-tracing with bulk
and scRNAseq and in vitro electrophysiological techniques in adult rhesus monkeys (Macaca mulatta) from our
currently funded grant (R01MH116008). We will use the cutting-edge Patch-Seq method for transcriptomic
profiling of individual electrophysiologically-characterized layer- and target- specific neurons. Differentially
expressed genes identified via single cell transcriptomics, will be validated using RNAscope and
immunohistochemistry (IHC) analysis, and will be correlated with specific functional properties of distinct ACC
cell types. We will specifically illuminate the molecular and physiological identity of ACCAMY and ACCLPFC
projection neurons that are implicated in regulating cognition, arousal and emotional stress. Findings from the
proposed study will form the basis of a larger program of studies to investigate how these neural signaling
properties are linked to neurochemical imbalance and responses to adverse conditions, such as oxidative stress
and inflammation. The proposed study will unravel the molecular underpinnings of laminar and functional
diversity of ACC circuits mediating affective behavior, which has broad therapeutic implications for understanding
susceptibility in stress-related disorders.

Public health relevance
PROJECT NARRATIVE Neuromodulation of cortico-limbic networks interlinking the anterior cingulate cortex (ACC) with the lateral prefrontal cortex (LPFC) and the amygdala (AMY) are critical for cognitive-emotional processing, but the cellular and molecular substrates are poorly understood in the primate brain. Using state-of-the-art single-cell RNAseq transcriptomics combined with tract-tracing and in vitro electrophysiological techniques, we propose to determine the molecular signature, neurochemical and functional profile of lamina-specific ACCAMY and ACCLPFC projection neurons that control arousal and stress. The proposed study will unravel the molecular underpinnings of laminar and functional diversity of ACC circuits mediating affective behavior, which has broad therapeutic implications for understanding neurochemical imbalance and susceptibility in stress-related disorders.